A Consortium for Gut-Brain Communication in Parkinson's Disease

Project Summary/Abstract
We plan to initiate participation in the NIH U01 Consortium for Gut-Brain Communication in Parkinson’s
Disease (PD) (GBPDC) including contribution of PD patients across the spectrum of disease, with and without
GI symptoms and age/sex matched healthy controls into the registry. The patients will be phenotyped with in
depth Parkinson’s and GI measures including clinical symptoms and physiology. A subset of the cohort will be
recruited from our specific center to participate in studies of brain gut imaging to assess meal-induced gut-
brain axis and autonomic alterations in PD. Data from the overall GBPDC phenotyping cohort will be used to
assess the relationship between measures of gastric function with autonomic metrics and Parkinson’s
symptoms (both GI and non-GI). Another subset at our center will under detailed sleep, circadian rhythm, GI
motility pattern assessments in an ambulatory setting and in an inpatient clinical research center to understand
the relationship between Parkinson’s disease desynchrony of central and peripheral circadian and sleep clocks
with GI dysmotility. Data from the entire registry cohort will also be analyzed to assess to the relationships
between PD dysfunction and gut motility.

Public health relevance
Project Narrative We plan to initiate participation in the NIH U01 Consortium for Gut-Brain Communication in Parkinson’s Disease (GBPDC) including contribution of patients into the where they will be phenotyped with in depth Parkinson’s and GI measures including clinical symptoms and physiology. Subsets of the cohort will be recruited from the Massachusetts General Hospital (MGH) to participate in studies of brain gut imaging to assess meal-induced gut-brain axis and autonomic alterations in PD and another subset will under detailed sleep, circadian rhythm, GI motility pattern assessment to understand the relationship between Parkinson’s disease desynchrony of central and peripheral circadian and sleep clocks with GI dysmotility.